Barriers to Screen for Domestic Violence among Women in Emergency Department

PROJECT SUMMARY ABSTRACT
Domestic violence (DV) includes physical and sexual violence, threats, economic, and emotional/psychological
abuse, or other abusive behavior as part of a systematic pattern of control and power perpetrated by one intimate
partner against another. It causes a significant burden for the healthcare systems by increasing morbidity and
mortality among victims. Women are disproportionately affected, although men may experience DV as well. The
recent COVID-19 pandemic led to movement restrictions and stay at home orders. While these decisions were
essential to prevent spread of the virus, such extended domestic stays may exacerbate the number the total as
well as reported incidents of DV. As a result, in recent years, DV has transformed into a shadow pandemic,
which further complicated this public health issue and increased the need to perform accurate and timely
interventions.
DV often forms a pattern, and many of the victims experience repeated acts of physical or mental abuse. Victims
of DV may seek care in hospital settings which makes timely interventions critical and even lifesaving. While
there is a serious need for government to reinforce commitments made to eliminate all forms of DV against
women, the health sector plays an essential role in breaking the cycle of abuse. Health providers can prevent
reoccurrence of such violent incidents by identifying women who are experiencing DV, and then provide
comprehensive services and train health providers in responding to the needs of survivors in addition to caring
for physical injuries. Abused women rarely disclose the reason for emergency department (ED) visit due to
various reasons including shame, fear of the perpetrator or financial dependencies. While these factors form
patient-specific barriers to screen for DV, the barriers to screening, detecting and helping DV victims can be
recognized at different levels during an ED visit. Since these barriers are not clear, more exploration is needed
to understand important features by analyzing EHR data to gain further understanding of the clinical experience
and environment.
In Aim 1 of this proposal, we will use the DV-related ICD-9/ICD-10 diagnosis codes to find positive cases of DV
among the visits to ED. Then adapt market-basket analysis, which is a data mining method originated in the field
of marketing, to our objective and identify patterns of injury and health problems which are observed together
frequently. Then, we will utilize state-of-the-art deep learning-based natural language processing (NLP) models
to learn the patterns in electronic health records clinical notes related to DV. In Aim 2, we will conduct semi-
structured interviews with ED health providers to investigate the barriers to screening for DV during patient-
provider encounter. The outcomes of this study have the potential to add significant insights to improve the
screening process and the care we provide our patients in the ED.
1

Public health relevance
PROJECT NARRATIVE Domestic violence incidents are highly under-identified which requires healthcare providers to be able to detect potential domestic violence-related visits by the structure of traumatic injuries, health problems (e.g., migraines, cardiovascular disease, abdominal pain), and verbal cues. We propose to analyze electronic health records associated to domestic violence related visits to emergency department, use data science techniques to identify injury and health problem patterns that frequently co-occur and apply deep learning-based natural language processing methods to learn verbal cues embedded in patient and provider narratives. Moreover, we will conduct semi-structured interviews with emergency department health providers to investigate the barriers to screen for domestic violence among women during patient-provider encounter. 1